Topical Drug Delivery System as an Anti-Inflammatory and Pro-Angiogenic Therapy for Diabetic Wound Healing

SUMMARY
Impaired wound healing in diabetic patients represents a major clinical problem, resulting in prolonged
hospitalizations and significant healthcare expenditures. The financial burden of this is extreme, representing
$78 billion annually in the U.S. alone. Two-thirds of all non-traumatic amputations are preceded by a diabetic
wound, and every 20 seconds a lower limb is lost to a diabetic wound. The impaired healing of diabetic wounds
is multifactorial, but a central pathogenic feature is chronic inflammation. These terrible, infection-prone ulcers
are difficult to treat using current technologies and represent a significant under-met need in the marketplace.
Current treatments commonly employed for these conditions involve standard bandages or basic hydrogels
which have many drawbacks, including that they cause inflammatory response, need to be removed and
changed often, and are not capable of sustained drug release. GelSana Therapeutics, Inc. is addressing this
need with its proprietary wound healing hydrogels that help heal wounds significantly faster and without the
downsides of today’s dressings. The hydrogels are based on polymers that repel protein adsorption and prevent
the foreign body response. Further, this class of materials have been shown to be anti-inflammatory. In studies
with diabetic mice with impaired wound healing abilities, GelSana has demonstrated that the hydrogels alone
cut the healing time down to 2/3 of the time of saline-treated diabetic wounds, matching the healing time of
healthy mice. This indicates that the material alone can correct the diabetic impairment to wound healing.
GelSana materials have also been shown to outperform another type of hydrogel used in commercially available
products in the time of healing required for these diabetic murine wounds. Furthermore, hydrogels laden with an
anti-inflammatory drug cut the healing time down by a staggering one-half. In this project, GelSana proprietary
zwitterionic hydrogels will serve as superior wound dressing materials to aid in correcting the diabetic wound
healing impairment by reducing inflammation, where sustained delivery of IL-10 from these dressings will be
demonstrated to further resolve chronic inflammation in the diabetic wound environment and improve
vascularization, thus allowing the diabetic ulcer to heal at a rate equivalent to or faster than that found in non-
diabetic (healthy) saline-treated wounds. This Phase I project will demonstrate feasibility for GelSana zwitterionic
hydrogels with and without IL-10 by (1) characterizing drug release and bioactivity in vitro and (2) assessing
efficacy in an in vivo murine diabetic ulcer model. This will be accomplished with these Aims: Aim 1: To quantify
the release rate and bioactivity of IL-10 from zwitterionic hydrogels. Aim 2: To quantify the impact of
sustained release of the drug on the ability of the drug-device product to improve wound healing in a
murine model. This work will result in a new class of anti-inflammatory pro-regenerative hydrogel wound
dressings with sustained release of novel therapeutics that combat oxidative stress and inflammation and
promote angiogenesis in diabetic wounds to therapeutically decrease inflammation, decrease healing time, and
increase tissue repair quality.

Public health relevance
NARRATIVE Impaired wound healing in ulcers that form on diabetic patients is a major clinical problem, with prolonged hospitalizations and significant healthcare expenditures of $78 billion annually in the U.S. alone, and with a desperate need for better treatment options. GelSana Therapeutics, Inc. is addressing this need with its proprietary wound healing hydrogels that have unique handling properties, help reduce inflammation in the wound bed, and are capable of providing sustained drug delivery to the wound bed over time to improve the diabetic healing response. Here, the impact of a GelSana hydrogel-drug combination product on diabetic wound healing will be determined, which could be critical for helping to correct the diabetic impairment to wound healing, and ultimately bring diabetic patients a new, much-needed healing option.